Emergents International Centers of Excellence for Malaria Research

CORE 1: ADMINISTRATIVE CORE
ABSTRACT/SUMMARY
The Émergents ICEMR is composed of a multinational, interdisciplinary leadership team and three Cores, all of
which are integrated seamlessly into the Consortium’s organizational and administrative structure. The
interdisciplinary nature of the proposed project requires substantial expertise in systems biology and OMICS
approaches (genomics, transcriptomics, lipidomics, proteomics), genomic epidemiology, molecular vector
biology and mathematical and statistical models. Program direction and supervision will, therefore, need sets
of equally important and complementary skills. The Leadership Team is led by Core 1 MPIs (Dinglasan, Happi
and Wondji) with direct support from a bilingual Program Coordinator, but the overall ICEMR steering committee
will be composed of all Co-Investigators from the consortium partner institutions and Center Cores. The
overarching objectives of the Administrative Core is to provide the leadership, administrative support, and
financial management to ensure the success of the Émergents ICEMR, through: (i) effective and efficient
administration, coordination and management of all activities associated with the program to ensure that the
program milestones are met; (ii) effective and efficient allocation of funds and maintenance of fiscal integrity;
and (iii) effective coordination and communication between collaborating Co-Is from academic institutions and
research institutes within the network. The organizational structure has clear lines of responsibility across
partner institutions with the University of Florida assuming responsibility for the overall success. The Émergents
ICEMR Administrative Core will be specifically responsible for leading Coordination of Malaria Surveillance
and Core Activities; implementing an Émergents ICEMR Performance & Evaluation Program; and working
closely with the NIAID-assembled Scientific Technical Advisory Group.

Public health relevance
CORE 2: ADMINSTRATIVE CORE PROJECT NARRATIVE The Émergents ICEMR is led by an experienced, multinational, interdisciplinary, and complementary leadership team and the implementation of a streamlined, decentralized organizational structure administrative structure. The overarching objectives of the Administrative Core is to provide the leadership, administrative support, and financial management to ensure the success of the Émergents ICEMR, through: (i) effective and efficient administration, coordination and management of all activities associated with the program to ensure that the program milestones are met; (ii) effective and efficient allocation of funds and maintenance of fiscal integrity; and (iii) effective coordination and communication between collaborating Co-Is from academic institutions and research institutes within the network. The Émergents ICEMR Administrative Core will be specifically responsible for leading Coordination of Malaria Surveillance and Core Activities; implementing an Émergents ICEMR Performance & Evaluation Program; and working closely with the NIAID-assembled Scientific Technical Advisory Group.